A Multimethod Approach of Social Disconnection in Schizophrenia: Leveraging Digital Phenotyping, Social Network Analyses, and Neuroimaging

Humans are inherently social and form meaningful relationships with family members and friends. However,
developing these relationships is difficult for Veterans with schizophrenia (SCZ), resulting in poor social
functioning and social disability. Two components of social disability are particularly devastating: objective
social disconnection (i.e., the number of social connections) and loneliness (i.e., the subjective discomfort of
feeling alone). Social disconnection and loneliness contribute to numerous detrimental outcomes, including
early mortality. Current evidence-based treatments are not sufficiently effective at improving social
disconnection and loneliness. Understanding how these constructs operate within naturalistic environments is
vital to generating novel treatments. However, social disability in SCZ has traditionally been assessed using
clinician-rated interviews, which have limited specificity in understanding the complexities of real-world
behavior. One goal of this proposal is to evaluate the relationship between social disconnection and loneliness
with digital phenotyping via smartphones. Digital phenotyping provides an ecologically valid assessment that
can elucidate the nature of social disability in real-time. Furthermore, it is crucial to elucidate the mechanisms
of social disconnection and loneliness that could further inform treatments. Although poor performance-based
social cognition is associated with neural activity in distinct brain regions, the extent to which neural activity
observed during social cognition paradigms relates to real-time social experiences in SCZ is unknown. Thus,
the second goal of this proposal is to examine associations between functional magnetic resonance imaging
(fMRI) during social cognitive tasks and digital phenotyping measures. Combining these methodologies can
inform us about the neurophysiological mechanisms of social disconnection and loneliness. In addition to
mechanisms at the neurophysiological level, mechanisms at the social level could also contribute to social
disability. The third goal of this proposal is to use Egocentric social network analysis (SNA) to examine
objective metrics of social networks. These metrics will provide information on how the structure and
composition of social networks impact real-time social processes. This Career Development Award (CDA-2)
aims to use an innovative, multimethod approach to examine the nature and mechanisms of social
disconnection and loneliness—two critical components of social disability. The knowledge gained from this
study could inform cutting-edge interventions for Veterans with SCZ that improve social disability at multiple
levels of analysis.
This CDA will provide the applicant, Samuel J. Abplanalp, PhD, with training in the areas of (1) social cognition
and social neuroscience of SCZ; (2) fMRI data processing and analysis; and (3) SNA methodology. The
applicant’s career goal is to become a VA-based data scientist, working to improve the social disability
experienced by Veterans with serious mental illness. The training outlined in this CDA application will lay the
groundwork for the applicant to develop an independent research program within the VA focused on applying
innovative methodologies to understand and improve social disability in SCZ. The VISN 22 Mental Illness
Research, Education, and Clinical Center (MIRECC) at the VA Greater Los Angeles Healthcare System (GLA),
and the University of California, Los Angeles (UCLA) provides an excellent environment and infrastructure to
complete the proposed study. The primary mentor will be Michael F. Green, PhD, the Director of the VISN 22
MIRECC Treatment Unit and the VA RR&D Center on Enhancing Community Integration for Homeless
Veterans (THRIVe), and an established researcher in the field of SCZ and social cognition. The applicant will
also receive specialized training from an expert in fMRI methodology (Robert Welsh, PhD) and a renowned
scholar in SNA methodology (Mark Handcock, PhD).

Public health relevance
Schizophrenia (SCZ) is a serious mental health disorder and is the most expensive per-patient condition within the VA, accounting for up to 20% of its healthcare budget. Pharmacological treatments help ameliorate acute symptoms of psychosis, including delusions and hallucinations; however, these treatments are resistant to impairments in everyday functioning, including impairments that contribute to social disability. Significant components of social disability are reduced objective connections with others (i.e., social disconnection) and the subjective experience of social disconnection (i.e., loneliness). The proposed study aims to leverage diverse methodologies to elucidate the nature and underlying mechanisms of social disconnection and loneliness. The knowledge gained from this project will inform novel interventions that target the specific components of social disability at multiple levels of analysis in Veterans with SCZ.